Small and Mechanosensitive Membrane Proteins Studied with DNA-based Tools

PROJECT SUMMARY
Membrane proteins (MPs) are molecules that can be found in membranes on the surface and the
inside of all cells. They enable vital cellular functions such as transport of water, salts and nutrients
across the membranes, sensing of the chemical and physical environment of the cell,
communication between cells, cell adhesion and energy conversion. MPs play a role in every
physiological and infectious disease and 60% of all FDA approved drug molecules target them.
To understand how exactly these proteins function, what role they play in different diseases, or to
simulate in a computer how new potential drugs would interact with MPs, the exact molecular
structures of the MPs need to be discovered first. As MPs are naturally embedded in lipid
membranes, they are not soluble in water and it is therefore much more challenging to solve their
molecular structures compared water-soluble proteins. Consequently, the molecular structures of
less than 100 out of ~8,000 human MPs are known.
This proposal will provide new DNA-based tools that will overcome many of these challenges for
MP structure determination. For this, DNA molecules without a genetic function are chemically
synthesized and self-assembled into ring-shaped DNA nanostructures. These rings can then be
filled with lipids and MPs, thus making MPs soluble in water. Moreover, these DNA-lipid nanodiscs
provide a native cell-membrane-like environment for the MP, which is important to keep MPs in
their native physiological state. By taking advantage of the programmable nature of chemical DNA
synthesis, and self-assembly, the size, chemical and physical properties of these nanodiscs can
be controlled with a precision and ease that alternative technologies do not provide. This will be
particularly useful for solving the structures of small MPs or mechanosensitive MPs, which are
actuated by molecular forces and stress in cell membranes.
It is expected that the DNA-based molecular tools from this research will overcome current
obstacles for MP structure determination and provide functionalities that current molecular tools
cannot offer. This research will therefore enable discoveries in structural biology, pharmacology
and virology, and thereby enhance the understanding and treatment of MP-associated diseases.

Public health relevance
NARRATIVE Membrane proteins are key molecules for many cellular functions and play a role in every infectious and physiological disease. Knowledge of the molecular structure of membrane proteins is necessary to understand the underlying biophysical and molecular mechanisms of their function. This research will enable solving membrane protein structures with novel tools that are made from DNA molecules.